Digital Object Identifer

The Department of Energy, Office of Scientific and Technical Information (OSTI) has been requested by the Department of Health and Human Services, National Institutes of Health (NIH) to register and manage Digital Object Identifiers (DOIs) for datasets resultant from the NIMH Data Archive (NDA) project, formerly named the National Database for Autism Research (NDAR).